Procure services to conduct a child care feasibility study for NCI at Frederick and NCI at Shady Grove

Procure services to conduct a child care feasibility study for NCI at Frederick and NCI at Shady Grove